Unveiling the Atheroprone Role of Novel Mechanosensitive Histone Modification

Project Summary/Abstract
The vascular endothelium, lining the inner surface of the arterial wall, responds dynamically to shear stress from
blood flow. Atheroprone shear stress reduces atheroprotective gene expression and induces endothelial cell (EC)
dysfunction, initiating atherosclerosis. Over the past decade, we and others have identified epigenetic and
epitranscriptional regulations that are integral to shear stress-regulated gene expression. Although epigenetic
regulation and histone post-translational modifications (PTMs) have been identified in ECs and other cells, the
full extent of histone PTMs, as well as novel histone codes, remain to be fully understood. Recently, we
discovered that O-GlcNAc occurs at the histone H3T32 site (H3T32OG) under atheroprone shear stress. A loss-
of-function mutation (H3T32A) decreased H3 O-GlcNAc and increased H3K27ac in promoters of
atheroprotective genes, suggesting systemic effects on chromatin accessibility and gene expression. To
investigate the role of H3T32OG in atherosclerosis, we created a mouse model with a tissue-specific H3T32A
mutation. These preliminary results led to the hypothesis that histone H3T32OG, as a novel histone code in
ECs, mediates atheroprone shear stress-induced EC dysfunction and atherosclerosis. Mechanistically,
H3T32OG competitively interacts with H3K27ac, ultimately restricting chromatin accessibility and
downregulating atheroprotective genes in ECs. To test this hypothesis, we propose the following three specific
aims: Aim 1: To elucidate the epigenetic features of H3T32OG in ECs under shear stress. Specifically, the shear
stress-induced H3T32 O-GlcNAc modification site will be validated by mass spectrometry. Then, the enrichment
of H3 O-GlcNAc will be identified by H3 O-GlcNAc ChIP-seq. Additionally, we will integrate H3 O-GlcNAc ChIP-
seq data with existing datasets to understand the shear stress-governed epigenetic features of H3T32OG. Aim
2: To delineate the role of shear stress-regulated H3T32OG in EC function. Specifically, step flow channel-
induced shear stress will be applied to mouse aortic ECs isolated from H3T32A mutation mice and their H3T32T
littermates. Gene expression profiles and cell lineage mapping will be elucidated by single-cell RNA-seq.
Furthermore, EC functional alterations between H3T32A and H3T32 will be evaluated in vivo and ex vivo. Aim
3: To investigate the effect of shear stress-regulated EC H3T32OG on atherosclerosis. We will evaluate the
potential differences in atherogenesis in male and female iEC-OGT KO ApoE-/- mice vs. their wildtype littermates,
as well as in iEC-H3T32A ApoE-/- and H3T32T ApoE-/- mice, by feeding them a high-fat diet or using a partial
carotid artery ligation model. This research will enhance our understanding of epigenetic mechanisms in ECs
and challenge current paradigms of histone modifications in health and disease.

Public health relevance
Project Narrative We recently identified a novel modification on histone H3 that increases in endothelial cells under disturbed blood flow, causing abnormal cell function. We propose to study the effect of this modification on endothelial dysfunction-caused atherosclerosis using both cell cultures and mouse models. This research will help us understand how blood vessel cells malfunction and how atherosclerosis develops.